Self-assembled multifunctional aptamer-complex biomaterial for precision medicine

Project Abstract
Self-assembled multifunctional aptamer-complex biomaterial for precision medicine
Oligonucleotide aptamers are a class of biomaterials that function as molecular ligands with high affinity and
specificity for a wide range of biological targets. Similarly to protein antibodies, aptamers bind to their cognate
targets via conformational recognition and thus, are often referred to as “chemical antibodies”. As small-sized
oligonucleotide biomaterials, aptamers can be rapidly synthesized and easily conjugated to various functional
agents for different clinical needs, and exhibit faster cancer-cell binding ability and deeper tumor-tissue
penetration than antibodies. The aforementioned features provide aptamers with notable advantages over
protein antibodies for clinical applications, and render them unique biomaterials for clinical use. Anaplastic large
cell lymphoma (ALCL) is the most common T-cell lymphoma in children. Biologically, lymphoma cells express
high-levels of the surface CD30 receptor, a signaling molecule regulating cell fate and a distinct biomarker for
ALCL diagnosis. Genetically, lymphoma cells express the Anaplastic Lymphoma Kinase (ALK) oncogene.
Currently, CHOP chemotherapy is the mainstay of treatment for ALK+ ALCL although is not ALCL cell-selective
or ALK gene-specific, and has serious adverse side effects.
To address these clinical challenges, we will develop a multifunctional aptamer-complex biomaterial through
self-assembly of functional oligonucleotides (aptamer and siRNA sequences) and self-loading of therapeutic
drugs. The formed aptamer-complex will act via three therapeutic modalities for simultaneous ALK+ ALCL cell-
targeted chemotherapy, gene therapy, and immunotherapy. We hypothesize that under CD30 aptamer
guidance, the aptamer-complex will specifically target ALCL cells and treat lymphoma through combination of
different cellular mechanisms, acting as (i) a chemotherapeutic killing lymphoma cells via cell-targeted drug
delivery, (ii) a gene therapeutic silencing ALK oncogene via aptamer-facilitated intracellular delivery of siRNA,
and (iii) an immunotherapeutic triggering apoptotic cell death via aptamer-mediated activation of cell CD30
signaling. To validate our hypothesis, the following studies will be conducted: To validate our hypothesis, the
following studies will be conducted: Aim 1: Formulation of self-assembled aptamer-complex biomaterial. Aim 2:
Functional validation of aptamer-complex. Aim 3: Preclinical study of aptamer-complex for precision therapy of
lymphoma. Aim 4: Preclinical pharmacokinetic and toxicity studies of aptamer-complex.
Technically, this study capitalizes on aptamer technology to develop a unique multifunctional biomaterial for
precision medicine. Scientifically, this study will provide a novel immunotherapeutic approach to treat ALCL by
stimulating cellular naïve apoptotic signaling via aptamer-mediated activation of CD30 receptors. Clinically, the
aptamer-complex will enhance therapeutic efficacy, reduce development of drug resistance in lymphoma cells,
and avoid off-target toxicity to normal cells/tissues, by combining three different targeted therapeutic
mechanisms.

Public health relevance
Project Narrative Self-assembled multifunctional aptamer-complex biomaterial for precision medicine Oligonucleotide aptamers are a class of biomaterials that function as molecular ligands with high affinity and specificity for a wide range of biological targets. Aptamers can be rapidly synthesized and easily conjugated to various functional agents for different clinical needs. Due to small size, aptamers exhibit capacity for faster cancer-cell binding and deeper tumor-tissue penetration than protein antibodies, rendering them the unique biomaterials for clinical use. Anaplastic large cell lymphoma is the most common T-cell lymphoma in children. The lymphoma cells are characterized by expressing CD30 biomarker and ALK oncogene. Current mainstream treatment for the lymphoma is a combined chemotherapy regimen. However, the chemotherapy is not lymphoma cell-selective or oncogene-specific, and thus, has serious adverse side effects in patients. To address these clinical challenges, this study will develop a multifunctional biomaterial through programed self-assembly of aptamer sequences and self-loading of therapeutic drugs. The formed aptamer-complex biomaterials will be able to simultaneously perform targeted chemotherapy, gene therapy, and immunotherapy specific for the lymphoma without side effects. To validate our hypothesis, preclinical study of the aptamer- complex biomaterial for precision therapy of the lymphoma will be conducted. Technically, this study takes advantages of aptamer technology to develop a new multifunctional biomaterial for precision medicine at low cost and minimal labor. Scientifically, this study will prove a novel immunotherapy approach to care the lymphoma by stimulating cellular naïve apoptotic signaling. Clinically, by combination of three different targeted therapeutic mechanisms the aptamer-complex biomaterial will empower therapy efficacy, reduce drug resistance potential of the lymphoma, and also avoid off-target toxicity to normal cells/tissues. Moreover, the developed multifunctional biomaterial approach will provide a universal platform to design precision medicine to treat other cancers.